Efficacy of intravenous sub-dissociative ketamine versus intravenous morphine in children with acute pain.

Project Summary
Pain is one of the most common reasons for children to visit an emergency department (ED) and is associated with short-
and long-term consequences when inadequately treated. Intravenous (IV) morphine is the prototypical and most
commonly administered parenteral analgesia for treating moderate to severe acute pain in children. However, IV
morphine is associated with acute adverse events such as respiratory depression and hypotension. In addition, there is
hesitation amongst caregivers and clinicians to administer opioids to children, leading to withholding or under-dosing
analgesics in children with pain and thereby perpetuating the undertreatment of pain and the resulting short- and long-term
sequelae. Ketamine is an NMDA-antagonist that has the potential to improve both short- and long-term sequelae of acute
pain experienced by children presenting to the ED. IV ketamine has been shown to be an effective and safe analgesic
when given using sub-dissociative doses to adults with acute pain in the ED or pre-hospital setting. Sub-dissociative
ketamine's analgesic efficacy and favorable safety profiles make it an attractive alternative to morphine. In addition,
ketamine may improve pain-related function and decrease potential long-term sequelae of acute painful events such as
chronic pain and medication dependency, post-traumatic stress disorder, anxiety and depression. The aims of this study
are to demonstrate that IV sub-dissociative ketamine is as effective as IV morphine for treating acute pain in children and
that its rate of cardiorespiratory events is substantially less compared to morphine. Additionally, we aim to determine if
children who receive ketamine will have better levels of pain-related function during the first week after ED presentation,
and have greater odds of experiencing more favorable post-traumatic stress, anxiety and depression outcomes up to 6
months following their ED visit. We will achieve these aims by conducting an 8-site phase 3 randomized clinical trial
within the Pediatric Emergency Care Applied Research Network (PECARN) comparing IV sub-dissociative ketamine to
IV morphine in children presenting to the ED with acute pain. We will enroll 1010 children 6 to 17 years of age with
moderate to severe acute pain and require IV morphine for analgesia. In addition, we will study children who most
commonly receive parenteral opioids in the ED, namely those with abdominal pain or extremity fractures. We will collect
measures of pain intensity and analgesic efficacy and assess for acute adverse events during the child's ED course and
conduct follow-up procedures assessing pain-related function, analgesic use/misuse, mental health and behavioral
outcomes up to 6 months after the index ED visit. The findings of this study have the potential to fundamentally change
how acute pain is managed in children and improve both their short- and long-term health. Achieving our aims would
provide the necessary evidence to inform guidelines and support a transition from morphine to a non-opioid analgesic
such as sub-dissociative ketamine as the primary treatment modality for children with moderate to severe acute pain.

Public health relevance
Project Narrative Pain is common in children presenting to the emergency department but is frequently undertreated, leading to both short- and long-term consequences. Morphine is the standard treatment for children with moderate to severe acute pain, but its use is associated with serious side effects and caregiver and clinician concerns related to opioid administration. Our research aims to demonstrate that sub-dissociative ketamine is as effective as morphine and a preferable alternative for treating acute pain in children because of its more favorable side effect profile and potential long-term benefits related to pain-related function, analgesic use/misuse, and mental and behavioral health outcomes.